Wisconsin State Laboratory of Hygiene FDA FERN program grant Laboratory Flexible Funding Model (LFFM) Research Program Cooperative Agreement RFA-FD-25-007 Discipline C: Radiochemistry

The Wisconsin State Laboratory of Hygiene (WSLH) is Wisconsin’s premier Public and Environmental Health
Laboratory and is part of the world-renowned University of Wisconsin – Madison School of Medicine and Public
Health, with a mission to improve and protect the human condition by providing accurate and precise testing,
service, research and education. The Radiochemistry Department is housed within the Environmental Health
Division (EHD) of the WSLH. The Radiochemistry Department has been a member of the Food Emergency
Response Network (FERN) for 18 years and interacts with members from state agencies such as the
Wisconsin Department of Health Services and federal agencies: FDA, FEMA, and EPA. The funding provided
by the FERN agreements has been critical in the Radiochemistry Department’s success. It has enabled the
department to maintain readiness to analyze food samples if called upon during a radiological food emergency.
The Radiochemistry Department is applying for all three tracks (C1, C2, C3) in the Radiochemistry Discipline
listed in NOFO: RFA-FD-25-007. The department has 4 chemical fume hoods for sample processing and
separation, 6 gamma spectrometers (HPGe detectors), 2 alpha spectrometers (8 channels each), 4 gas
proportional counters (4 detectors each), an automated gas proportional counter (50 sample capacity) and a
liquid scintillation counter. The Trace Elements Clean Laboratory (housed within EHD at WSLH) has ICP-MS
instrumentation that could also be utilized for analysis in a radiological food emergency. The department has
trained staff experienced in analyzing alpha emitters (Am, Pu, Ur, gross alpha), beta emitters (Sr-90, H-3,
gross beta), and gamma emitters for a variety of matrices (water, air, milk, vegetation, soil, fish, and an
assortment of foods (successfully completed all FERN food challenge samples). In addition, the laboratory has
worked on a variety of FDA sponsored projects, recent projects include: “LFFM Multi-Lab Validation Study on
Screening for Gross Alpha and Beta in Food using GPC and LSC” and “Radiostrontium Matrix Extension
Study”. The unit is audited and accredited by the EPA and was recently audited by FEMA with no deficiencies
cited. The unit has validated SOPs in place to analyze a variety of radionuclides with different matrices and
adheres to strict quality control parameters that includes participation in a variety of proficiency testing
programs to show competency. We are centrally located within the United States, in a critical part of the
nation’s food network. We also have numerous power plants located in or near the state’s border that we
provide surveillance for (over 900 surveillance samples per year). Our laboratory has significant experience in
emergency response events and exercises. The Radiochemistry Department has the instrumentation,
validated methods, experienced staff and the knowledge in place, as well as the capacity and capabilities, to
analyze samples in the event of a radiological food emergency and to exceed all aims specified in the funding
opportunity. The funding associated with this grant is critical in maintaining these capacities and capabilities.

Public health relevance
Project Narrative Funding from this grant would enable the Wisconsin State Laboratory of Hygiene’s Radiochemistry Department to maintain readiness to analyze human and animal food samples for radioactivity if called upon by the FDA or other agency to analyze food samples in the event of a radiological food incident. The funding would be utilized to ensure adequate staff are trained in applicable validated methods and instrumentation is ready and available. Finally, funding would also allow the department to advance its capabilities and capacity to analyze food to ensure that the nation’s food supply is safe.